Online Parent Media Literacy Program to Promote Preadolescent Health

Abstract
Preadolescence is a critical window of development during which beliefs and behaviors related to gender roles,
appearance ideals, romantic relationships, and sex are adopted, impacting proximal and distal health
outcomes. Parents are influential in shaping their children’s beliefs and behaviors, and high-quality parent-
child communication can serve as a protective factor to improve youth health outcomes. However, parents
often struggle with effectively communicating with their children about these topics, especially within the
context of the declining age of puberty. For preadolescents, media are gender and sexual socializing agents, and
the messages they receive about appearance, gender roles, relationships, and sex are often stereotypical,
unrealistic, and inaccurate. Parents can attenuate the potentially harmful impact of media on their children
through parental media mediation, and parenting programs using media literacy education (MLE) have been
shown to favorably impact youth health outcomes. The first aim of this project is to create MAP-Tween, a web-
based program designed to provide parents of preadolescents with media mediation skills, knowledge about
preadolescent development, and practice in high-quality parent-child communication about puberty and
sexual development, gender stereotypes, relationships, and sex. Program development will be enhanced by a
diverse advisory panel of parents, preadolescents, key stakeholders (e.g., schools, community-based
organizations), and expert consultants. The second aim of this project is to conduct a feasibility study of MAP-
Tween in which a diverse sample of parent-child pairs (preadolescents ages 9-12 and their parent/guardian;
N=300) are randomly assigned to either the intervention group (receive MAP-Tween) or an active control
group (review online PDFs of medically accurate information on preadolescent development). Parents and
tweens will complete pre-post assessments, which will provide a preliminary test of program effectiveness for
positively affecting outcomes. It is hypothesized that this program will enhance parental media mediation and
parent-child communication frequency and quality, and in turn, positively impact preadolescent health-related
outcomes. This project shifts the prevention paradigm to focus on the early antecedents of sexual and
relationship health and sexual violence and fills a gap in evidence-based programs for parents of
preadolescents to help them engage in high-quality communication with their child about these important
topics. MAP-Tween will be the only evidence-based parent program that explicitly addresses the influence of
media on preadolescent health. The program uses highly interactive web-based functionality that allows for a
customized user experience including the ability for parents to select specific program content and “post” it to a
section of the program for their children to access and develop a customized family media plan. This project
would evaluate preliminary effectiveness and feasibility of MAP-Tween and determine if a future larger-scale
study with mediator and moderator analyses and longer-term follow-ups is warranted.

Public health relevance
Project Narrative Parents influence preadolescents’ beliefs and behaviors related to gender roles, appearance ideals, romantic relationships, and sex, but struggle with effectively communicating with their children about these topics, especially within the context of the declining age of puberty and the pervasive influence of media. The purpose of this project is to develop and test the feasibility of web-based program for parents of tweens designed to enhance parent-child communication about body-image, gender role stereotypes, romantic relationships, and sexual development and parental media mediation with the aim of positively impacting preadolescent health- related outcomes. The proposed research has the potential to change the field of sexual health promotion and sexual violence prevention by shifting the prevention paradigm to focus on the early antecedents of sexual health, addressing the influence of media on gender and sexual socialization, and filling a gap in programs for parents of tweens.